DRUG METABOLISM AND DETOXIFICATION IN THE EYE

We have previously shown that the inducibility by aryl hydrocarbon (Ah) of cytochrome p-450-mediated monoxygenases in the eye id genetically regulated (Ah lociO. We have also shown that drug metabolizing(Ah hydroxylase) and detoxifying(GSH S-transferase) activities are highest in the uvea. Reactive oxygen species (O2 and H2O2) are generated by Ah loci-associated monoxygenases and enhanced during drug metabolism. Both drug metabolites and reactive oxygen species are detoxified by GSH. It is therefore evident that GSH plays an important role in drug detoxification in the uvea. In the anterior uvea, saturation of detoxification capacities of the ciliary body by excess doses of GSH depleting drug(acetaminophene) causes cataract in Ah loci-expressive mouse strains but not in nonexpressive strains. It is therefore proposed to investigate the mechanism of GSH-metabolic detoxification and its genetic control using a perfused eye. We have obtained evidence suggesting a possible correlation between the Ah loci and retinal degeneration in mice. This possibility is investigated in more detail using F1 and F2 progeny of crosses between Ah loci-expressive and nonexpressive inbred mouse strains. Labilization of pigmented-epithelium lysosomes by reactive drug metabolites was suggested to be a factor involved in retinal degeneration. If this is the case, increased detoxification of reactive metabolites by GSH would prevent the degeneration. It is therefore proposed to test whether enhanced GSH conjugation, inhibition of Ah loci-mono-oxygenases, and increased GSH level prevent or delay the onset of retinal degeneration.